Effect of small molecule activator of autophagy on insulin signaling, senescence, and neuropathology in mouse models of Alzheimer's disease

PROJECT SUMMARY
Although Aduhelm and Leqembi were recently approved for treating Alzheimer's disease (AD) patients, the
reversibility and long-term benefits to patients remain far from reality. Accumulating data suggest that insulin
resistance and markers of senescence increase during normal aging and even more so in AD as reflected by
colocalization of neurofibrillary tangles (NFTs) and senescence markers in the neurons of both AD patients and
mouse models of AD. Also, the impaired autophagy-lysosome pathway (ALP) is known to accelerate
senescence, and restoring ALP has been shown to reverse senescence. Therefore, ALP activators are
predicted to be excellent drugs to ameliorate multiple pathologies of AD including senescence.
Our recently published data suggest that TFEB, a master regulator of ALP, protein levels are reduced in AD
brains, TFEB expression by genetic approach reduces lipofuscin, increases lysosome and mitochondria
biogenesis, and improves cognition. Considering the enormous potential for TFEB activators, we developed a
high-content screening assay and identified TPI-132 as a potent activator of TFEB and ALP. TPI-132 dose-
dependently dephosphorylated TFEB, has relatively low toxicity, and rescues doxorubicin- and d-galactose-
induced senescence in cell lines and primary neurons. However, TPI-132 has low brain penetration. We also
found mTOR-independent and calcineurin-dependent mechanism of TPI-132 to dephosphorylate and activate
TFEB. Interestingly, we found that TPI-132 administration in old 3xTg mouse model of AD rescued age-
associated insulin resistance dose-dependently. More importantly, TPI-132 increased ADAM10/sAPPα levels
in the mouse brain following chronic administration. Based on these data, we hypothesize that by modulating
TFEB and autophagy activity, TPI-132 increases neuroprotection, mitigates insulin resistance and senescence
thereby improving Alzheimer's pathology and cognition. Aim 1 is designed to hit to lead optimization to
increase potency and brain permeability, by synthesizing six sets of new compounds with structural diversity.
Two best compounds with increased TFEB activity, reduced toxicity, and improved brain penetration and
solubility will be selected to test in Aim 2. In aim 2, the selected two analogs will be tested in primary neurons
from AD mouse models and iPSC-derived neurons from AD patients on senescence, dendritic spines, and
Aβ/tau pathology. In aim 3, TPI-132 and the two best analogs will be administered to 3xTg and PS19 mouse
models of AD by i.p. injections at 2 ages, 11 and 17 months for one month. The compounds' effect on insulin
tolerance, senescence, synapses, protein aggregates and ALP activity will be quantified and correlated with
cognition and compound levels in the brain. TPI-132 is more promising than other reported TFEB activators
because besides anti-senescence effects, it increases two powerful neuroprotective factors, ADAM10/sAPPα
and thus can be further developed and tested in clinical trials in future studies as new class of drugs for AD.

Public health relevance
PROJECT NARRATIVE Despite tremendous research efforts and numerous clinical trials, a successful disease-modifying therapy has not been identified for Alzheimer's disease. Because of the failure of autophagy, toxic protein aggregates accumulate in the neurons, which is responsible for multiple pathological hallmark features seen in Alzheimer's patients. Here we want to test whether a small molecule compound that has been demonstrated to reduce senescence can increase autophagy or self-eating thereby clear cellular debris in neurons, decrease senescent cells, rescue insulin resistance, increase synapses and prevent cognitive decline in models of Alzheimer's disease.